BB2: Using Baby Books to Improve Maternal and Paternal Parenting and Child Outcomes

PROJECT SUMMARY There is no change from the Project Summary submitted in the parent application.

Public health relevance
PROJECT NARRATIVE There is no change from the Project Narrative submitted in the parent application.